An internet CBT intervention for pediatric chronic pain and disability

DESCRIPTION (provided by applicant): An estimated 15% to 30% of otherwise healthy children and adolescents suffer from recurrent or chronic pain such as headache, abdominal pain, and musculoskeletal pain. Chronic pain results in a measurable decline in children's functioning and produces economic burden on families. Effective treatment that targets these children may also lessen the risk of continued pain and disability into adulthood. There is recognition of the potential of psychological treatments, principally cognitive-behavioral therapies (CBT), for decreasing pain and disability in children. However, even where effective treatments have been developed, most children do not receive psychological intervention for chronic pain management due to barriers such as problems with access to treatment, lack of trained clinicians, expense, insurance limitations, or attitudes about psychotherapy. These problems have led to the consideration of alternative forms of treatment delivery such as through the Internet. We have already made significant progress in developing and conducting an initial evaluation of a psychological intervention delivered online called Web-based Management of Adolescent Pain (Web-MAP). Our findings indicated that children in families that received this intervention experienced significant reduction in activity limitations and pain intensity compared to children in a wait-list control group. The proposed project is designed to extend these findings and will determine (1) whether treatment effects can be maintained beyond the immediate post-treatment period, (2) whether findings generalize across individuals recruited from other medical centers, (3) whether other child outcomes such as pain-specific anxiety and sleep quality are impacted, and (4) how treatment results compare to online patient education. In this application, we plan to evaluate the efficacy of Web-MAP in a large multicenter sample of 300 children and adolescents (ages 11-16 years) with chronic pain and their parents recruited from pain centers across the U.S. and Canada. The study design is a 2 (group) x 4 (time point) randomized controlled trial. All participants will be receiving evaluation from a specialized pediatric pain clinic. In addition, participants will be randomly assigned to receive online access to either patient education (attention control condition) or CBT over an 8-week treatment period. The primary study outcomes are child activity limitations and pain measured at pre-treatment, immediately post- treatment, and at 6- and 12-month follow-ups. Secondary outcomes include child reported depression and anxiety symptoms, parental behaviors, treatment satisfaction, sleep quality, and service use. We will also evaluate demographic and individual factors that predict treatment response. This project represents a significant advance in the development and testing of innovative approaches to deliver psychological therapies for youth with chronic pain, which may guide future developments in CBT for pediatric chronic pain. The long- term goal of this research program is to develop effective and flexible treatments that can be delivered at low cost to reduce pediatric chronic pain and pain-related disability.

Public health relevance
PUBLIC HEALTH RELEVANCE: Use of the Internet to deliver psychological treatment to children and adolescents with chronic pain provides a flexible and cost-effective way of reaching families who may not otherwise access mental health services. The long-term goal is provide effective treatment to prevent the development of adult chronic pain, disability, and psychopathology. Project Narrative Use of the Internet to deliver psychological treatment to children and adolescents with chronic pain provides a flexible and cost-effective way of reaching families who may not otherwise access mental health services. The long-term goal is provide effective treatment to prevent the development of adult chronic pain, disability, and psychopathology. __SpecificAimsTextDelimiter__ Specific Aims Children report severe chronic pain as frequently as adults, with 8% reporting a period of significant disability and distress [58; 73]. Effective treatment that targets these children may also lessen the economic and social impact of chronic pain in adulthood. [There is recognition of the potential of psychological treatments for decreasing pain and disability in children[12]. However, even where effective treatments have been developed, most children do not receive psychological intervention for chronic pain management[55], a problem that has led to the consideration of alternative forms of treatment delivery such as through the Internet. The Internet is an ideal medium to provide behavioral and illness self-management interventions because many children and parents have familiarity with this mode of communication, access the Internet regularly, and frequently search for health information online. Examples of successful Internet-delivered psychological treatments are evident for many other health problems (e.g., headache, tinnitus)[8]. Work on Internet-delivered treatments is in the very early stages of development in pediatric chronic pain.] [We propose that children and adolescents with chronic pain represent an important population who might benefit from this innovative approach to treatment delivery]. We have already made significant progress in developing and conducting an initial evaluation of a psychological intervention delivered online called Web- based Management of Adolescent Pain (Web-MAP). Our preliminary findings indicated that children in families that received this intervention experienced significant reduction in activity limitations and pain intensity compared to children in a wait-list control group[43]. However, further studies are needed to determine (1) whether treatment effects can be maintained beyond the immediate post-treatment period, (2) whether findings generalize across individuals recruited from other medical centers, (3) whether other child outcomes such as anxiety and sleep quality are impacted, (4) how treatment results compare to online patient education, [and (5) what individual factors predict treatment response.] The long-term goal of this research program is to develop effective and flexible treatments that can be delivered at low cost to reduce pediatric chronic pain and pain-related disability. The objective of this application is to evaluate the efficacy of an Internet-delivered CBT intervention among a cohort of children with chronic pain recruited from pain centers across the U.S. and Canada. Specific aims and hypotheses are: Aim 1: Determine the efficacy of Web-MAP in treating youth with chronic pain via a randomized controlled multicenter trial. Hypothesis 1: Children and adolescents in families that receive the Web-MAP intervention report improved daily function and decreased pain intensity compared to children and their parents who receive online patient education, as assessed immediately post-treatment and at 6- and 12-month follow-ups. Hypothesis 2: Children and adolescents who receive the Web-MAP intervention report better sleep quality and fewer depression and anxiety symptoms compared to children who receive online patient education at post-treatment and at 6- and 12-month follow-ups. [Hypothesis 3: Parents (and children) who receive the Web-MAP intervention report more adaptive parental responses to pain compared to parents (and children) who receive online patient education at post- treatment and at 6- and 12-month follow-ups.] Aim 2: Compare service use among treatment groups from pre-treatment to 12-month follow-up. Hypothesis 4: The Web-MAP group incurs fewer health (e.g., outpatient visits) and community services and has less out-of-pocket expenses and lost employment time compared to families in the online patient education control group from pre-treatment to 12-month follow-up. Aim 3: [Exploratory aim: Examine individual factors that predict treatment outcome]. [Hypothesis 5: Demographic factors (e.g., child age, sex), and pre-treatment psychological variables (depressive and anxiety symptoms) predict treatment outcomes.] Hypothesis 6: Prior experience with the Internet and [parental education] predict treatment success, where less prior experience with the Internet [and lower levels of education] correlates with lower completion rates and poorer treatment outcomes. Innovation and Approach: The proposed research is highly innovative, representing the first multicenter trial of CBT for pediatric chronic pain management. Use of the Internet to deliver psychological treatment to children with chronic pain may be critical to [providing flexibility in the delivery of evidence-based treatment to a large number of patients at a low cost]. Furthermore, multi-site recruitment is a key step in demonstrating generalizability of the intervention and provides a larger sample for a stronger test of treatment efficacy. [Internet interventions may complement and extend options for treatment delivery, which has the potential to contribute significantly to treatment advances for pediatric chronic pain].